Infant Assessment of Early Communication Risk Factors : The ISCBS (formerly ECBS)

DESCRIPTION (provided by applicant): Effective early intervention depends on reliable identification of risk for communication impairments as soon as possible. Established infant risk factors for communication impairments include poor turn taking, gestures, receptive language, commenting, symbolic play, and speech. Although these risk factors can be detected by 12-18 mos. and reliably predict later language and social development, attempts to detect similar risk factors in children 2-12 mos. have been unsuccessful because of extreme limitations in available assessments that typically include only 4-6 items for these infants' preintentional communication (i.e., reactive or active infant communication behaviors that are not directed toward listeners). There are no available normed assessments that provide comprehensive and dynamic data on infant preintentional communication and reflect evidence-based predictors that discriminate infants at risk for communication impairments before 12 months. When practitioners cannot detect infant behaviors known to be associated with communication risk, they cannot target early intervention to children with the greatest needs and potential for improvement. If we can identify communication risk early enough, we can intervene in the skills that predict later communication impairments and potentially mitigate effects of primary impairments in children and reduce the likelihood of secondary impairments that affect communication and other life skills. The plan for this project is to refine and complete norming for a predictive, comprehensive, modality-independent assessment to detect communication risk in preintentional infants 2-12 months (the Infant Social Communication Behavior Scales, or ISCBS). Phase I research by the present grant team showed that a short probe could reliably elicit preintentional communication behaviors from infant's age 2-12 months that represent 12 predictors of communication risk. These 12 predictors can be reliably and validly scored and grouped into 6 domains that correspond to 6 behavior clusters for the leading dynamic communication assessment for toddlers, the Communication and Symbolic Behavior Scales (CSBS; Wetherby & Prizant, 1993). A clear prediction of communication risk could justify the early involvement of speech-language pathologists for infants as well as for older children who have complex communication needs. We will do final revisions of the ISCBS based on Phase I results and create nationally representative norms by administering the ISCBS to 220 new samples of typically developing infants 2-12 mos., and conducting follow-up assessments with these infants and a previous cohort of 134 infants at 30-36 mos. for a total normative sample of 354 children, to achieve these specific aims: refine the ISCBS, and associated training materials to improve ease of administration and scoring, confirm ISCBS items, scales, domains, and composite that account for domains that discriminate by age and at-risk disability status at three years from ISCBS infant samples, and establish the reliability, validity and age-based norms of the scales, domains, and composite scores for the ISCBS in nationally representative samples of typically developing infants using correlational analyses, including confirmatory factor analysis.

Public health relevance
PUBLIC HEALTH RELEVANCE: We have recognized the need for detecting communication problems as early as possible so that we can start essential early communication intervention, but we do not presently have assessments that provide us enough information about how communication looks different in infants under 12 months at risk for communication disabilities. The Infant Social Communication Behavior Scales (ISCBS) would be the first comprehensive and normed assessment of communication for infants 2-12 months. With this tool, we could enhance our ability to provide clinical assessment and intervention to hone in on key communication skills during this period that make the greatest public health impact for infants with suspected communication risk factors. We can also use the ISCBS to develop better intervention strategies for older children and adults who continue to need support with these early communication skills for longer than 12 months, and to predict effective changes in these early communication skills that vitally enhance quality of life and interaction for persons with significant communication challenges.